Genomic and Functional Studies of Dysplasia-Associated Arterial Diseases

Project summary
Fibromuscular dysplasia (FMD) is a non-atherosclerotic, systemic arteriopathy with excess burden on women.
FMD may have varying manifestations, including hypertension, stroke and myocardial infarction, among
others, depending on the arterial beds involved by arterial stenosis, aneurysm, dissection or tortuosity. Arterial
dissections are recognized as a major manifestation and cause of substantial morbidity and mortality risk.
Genetic susceptibility loci for FMD and arterial dissections identified thus far implicate arterial smooth muscle
and its corresponding extracellular matrix. The genetic architecture of these arterial diseases is emerging as
variable, with contributions of a complex genetic architecture, rare heritable variants in a subset of cases, and
potential modifier genes. The proposed studies will build upon the R35 awarded to Dr. Ganesh to support the
training of postdoctoral fellow Cameron Pinnock, PhD and evaluate the genetic and allelic spectrum of
spontaneous coronary artery dissection (SCAD) and FMD in novel bioengineered cellular and tissue models.
These studies are within scope and fully aligned with the goal of the R35 award as originally stated to precisely
define the genetic basis of arterial fibrodysplasia and employ relevant model systems for gene and variant
mechanistic testing, resolution of genetic variants of uncertain significance, testing influences of potential
modifier genes, and analysis of gene regulatory mechanisms, particularly those relevant to vascular sex
differences and female-biased cardiovascular disease. We will test the hypothesis that the genetic influences
on FMD and SCAD alter the vascular smooth muscle matricellular unit in manners that render the artery
susceptible to loss of tissue integrity. The expected outcome of the proposed studies will be the successful
integration of genomics and functional studies with new engineered models that provide new insights into the
mechanisms of arterial dysplasia.

Public health relevance
Project Narrative: Fibromuscular dysplasia (FMD) is an arterial disease that can cause stenosis (inward growth), aneurysm (outward growth), dissection (tearing), or tortuosity (abnormal bending) of blood vessels, leading to manifestations such as high blood pressure, stroke, heart attacks, and death. These dysplasia-associated arterial diseases are estimated to occur in 1-4% of the U.S. population and most often afflicts women. This study will use genetic and laboratory approaches to discover and characterize the involved genes and understand their functions in causing pathologic changes in the arterial wall, leading to the cardiovascular manifestations; the biologic insights from this study will be important for developing novel diagnostic and therapeutic strategies.